Elucidating the temporal mechanism of vancomycin kidney toxicity as a means to prevent injury

Project Abstract: There is a fundamental need to understand the temporality of the mechanism for Vancomy-
cin Acute Kidney Injury (VAN AKI) because mechanistic knowledge to date has not led to safer care. However,
doing so requires serial biopsy and has been deemed impossible in traditional rodent experiments and unethi-
cal in humans. Our swine model of intubated, sedated, and paralyzed pigs offers physiologic and situational
similarity to human critical illness and further allows serial biopsy and moderate volume phlebotomy. Defining
the inciting mechanism will pave the way for AKI prevention studies that will precisely target: A) avoidance of
cellular accumulation such as through cellular uptake at the proximal tubule cell for vancomycin and many
other nephrotoxins, e.g., megalin mediated uptake or B) tubular conditions that minimize the likelihood of uro-
modulin complex formation, e.g., osmotic gradient management. The long-term goal of this research program
is to improve the kidney safety profile for critically necessary antibiotic therapies. Vancomycin (VAN) is an ex-
emplar study drug, as it is the most prescribed antibiotic in the hospital setting and causes kidney damage that
leads to excess morbidity and mortality. The objectives of this application are to: 1) define the mechanistic
temporality of VAN AKI so that prevention strategies can be focused later and 2) identify the metabolomic path-
ognomonic signature in blood that precedes VAN AKI. The central hypotheses in this proposal are that: 1)
temporality of the previously defined VAN AKI mechanisms is critically important, with the first event initiating a
chain reaction leading to toxicity. Identifying this ignition point will allow prevention strategies to be precisely
targeted, and 2) characterizing the blood metabolome will identify pathognomonic signatures that precede sus-
tained injury and will represent substantial improvements over the status quo monitoring approaches such as
serum creatinine or urinary biomarkers that are subject to variability from dilution. The rigor of prior research
demonstrates that: 1) VAN causes histopathologic kidney damage and changes to glomerular filtration rate. 2)
Our very small pilot data with three swine demonstrate promise for identifying metabolomic signatures that pre-
cede AKI. In this proposal, we AIM to 1) Determine the inciting mechanism and temporality of vancomycin AKI
in swine and classify the corresponding the changes in glomerular function and other gold standards and 2)
Characterize the blood metabolome of swine that develop and do not develop AKI. This project is innovative
as no previous approaches have been able to answer mechanistic temporality, and identifying blood metabo-
lomic signatures is likely to advance the status quo for timely kidney injury detection. Identification of early in-
jury is especially translational since it will be identified from a model that is physiologically and situationally sim-
ilar to the human condition of critical illness. These contributions will be significant because VAN kidney injury
is common with current approaches, and proposed methodologies are relevant to understanding other drugs
(e.g., polymyxin b and cisplatin) that cause AKI. Results from this proposal will lead to directed clinical trials.

Public health relevance
Project Narrative: The proposed research is relevant to public health because vancomycin is the single most commonly administered antibiotic in the hospital setting, causing attributable acute kidney injury in more than 10% of patients and leading to 300,000 potentially preventable new kidney injuries per year. Despite known mechanisms, it is unknown if proximal tubular necrosis via an oxidative mechanism or vancomycin uromodulin complexes leading to obstruction/renal tubular epithelial dam- age is the initiation event that begins a pathway of damage. Defining the inciting mechanism will pave the way for AKI prevention studies that will precisely target: A) avoidance of cellular uptake at the proximal tubule cell for vancomycin and many other nephrotoxins, e.g. megalin mediated uptake or B) tubular conditions the minimize the likelihood of uromodulin complex formation, i.e. osmotic gradient management.